The Pulmonary Lymphatics in Inflammation and Disease

PROJECT SUMMARY/ABSTRACT
Pulmonary lymphatic vessels are thought to be critical for lung function due to the vulnerability of the lungs to
edema and their constant exposure to pathogens. Indeed, abnormal pulmonary lymphatics are seen in
association with nearly every chronic lung disease including transplant rejection, pulmonary fibrosis, and
emphysema, which combined affect nearly 32 million Americans. However, it remains unclear whether these
abnormal lymphatics are a consequence of the disease or if lymphatic dysfunction is pathogenic, leaving
potential therapeutic targets unexplored. This proposal addresses both an outstanding gap in our ability to study
pulmonary lymphatic function and also investigates the basic role of lymphatics in lung disease using two novel
mouse models of impaired pulmonary lymphatic flow. The first model uses Clec2-­mutant mice, which have
severely impaired lymph flow due to an absent platelet plug at the lympho-­venous junction and retrograde flow
of blood into the lymphatic system that prevents lymphatic drainage. In the second model, lung-­specific lymphatic
deletion is achieved by inducing diphtheria toxin-­mediated cell death of lymphatic endothelial cells in mouse lung
transplants. These models show that lymphatic dysfunction leads to accumulation of leukocytes and formation
of lymphoid tissue in the lung parenchyma. Significantly, mice with impaired lymphatic flow also have alveolar
enlargement and lung injury that resembles human emphysema. In Aim 1 of this proposal, both models will be
used to investigate the role of pulmonary lymphatics in leukocyte trafficking and test whether lymphatic function
plays a role in immune cell specification and the inflammatory milieu of the lung. Aim 2 will use pulmonary
function tests, CT imaging, and expression studies to test the hypothesis that lymphatic dysfunction causes a
spontaneous emphysema phenotype in mice, and will investigate the mechanism by which lymphatic dysfunction
causes lung injury using rescue studies. These studies are predicted to provide in vivo models for understanding
the interplay between lymphatic function, inflammation, and lung injury and may uncover an unappreciated role
for lymphatics in emphysema. This proposal also plays a central role in a career development plan for becoming
a successful independent investigator focused on vascular biology and disease. The training plan described here
provides an opportunity to gain expertise in mouse modeling of human disease, transcriptomics, and physiologic
and radiographic analysis of the mouse lung. The University of Pennsylvania is an ideal environment in which to
execute this training plan not only because of its excellent physical resources, but also because of its intellectual
community of researchers with a track record of strong mentorship of early stage investigators.

Public health relevance
Chronic lung disease, which includes asthma, pulmonary fibrosis, and emphysema, affects nearly 32 million Americans and is the third leading cause of death in the United States. We have found evidence that impairment of specialized vessels known as lymphatics in the lungs of mice leads to the accumulation of white blood cells and inflammation that has the potential to cause destruction of lung tissue. In this proposal, we aim to uncover a link between lymphatic dysfunction, white blood cell accumulation, and lung damage due to inflammation, and in the process, move closer to new therapies targeting the impaired lymphatics that may improve the lives of patients suffering from chronic lung disease.